Investigation of a Novel Cancer Stem Cell Population in Ependymoma.

PROJECT SUMMARY
Brain tumors have become the leading cause of cancer-related death in children. Ependymoma (EPN)
accounts for a substantial number of these deaths, and unlike in medulloblastoma, no effective chemotherapy
has been identified. Most pediatric ependymomas, unlike in adults, occur in the posterior fossa. While
aggressive surgery and radiation improve the initial results but even in completely resected and radiated
posterior fossa ependymoma the 10-year progression survival is very poor with only approximately one third of
these children being without relapse. All relapsed children with ependymoma will relapse again and all will die,
often after multiple relapses with damaging repeated surgeries and radiation. There is a desperate need to
understand the biology of these tumors better to understand the high, and often delayed, relapses. Bulk
examination of childhood ependymoma samples has allowed classification within ependymoma which has had
identified subpopulations with early relapse risk but has had no impact on therapy or long-term outcomes.
Given that relapses are late, seen most frequently in children who have had complete surgeries and are
radiated, we hypothesized that relapses occur from a relatively small number of resistant cancer stem cells
present at diagnosis. Preliminary data using single cell RNA seq on posterior fossa ependymoma strengthens
this hypothesis and identifies a putative cancer stem cell subpopulation amongst 4 distinct subpopulations.
This grant rigorously explores whether we have indeed identified a cancer stem population in childhood
ependymoma. Our research intends to fully characterizes the distinct ependymoma subpopulations identified
in single cell RNA seq. Potentially targeting a stem cell population at diagnosis in addition to surgery and
radiation may improved outcomes for a pediatric brain tumor that has substantial mortality.

Public health relevance
PROJECT NARRATIVE Childhood ependymoma is an aggressive malignant brain tumor with a very high, and often late, recurrence rate. We have identified tumor cells in ependymoma which appear to be “stem cells” that are capable of regrowing tumor even after previous apparent complete removal at surgery. Confirmation, and further analysis, of these stem cells will provide novel targets to reduce the high recurrence rate in ependymoma.